IND-Enabling Development of HIV Maturation Inhibitors Formulated for use as either Oral or Long-Acting Parenterally Administered Agents

Project Summary: While currently available HIV therapies are highly effective, they are not
curative. Patients are required to remain on life-long therapy which is associated with a variety of
adverse effects. Viral-mediated drug resistance poses an increasingly serious problem,
particularly in resource-limited settings. The development of new classes of inhibitors that block
viral replication distinct from those targeted by current therapies is a high priority. Maturation
inhibitors (MIs) represent one such class of HIV therapies. MIs block virus replication by disrupting
the conversion of the capsid precursor protein, CA-SP1 (p25), to the mature form of capsid, CA
(p24) resulting in the release of non-infectious viral particles. Unlike protease inhibitors that bind
to and inhibit the action of the viral protease, MIs directly target the HIV-1 Gag protein. This distinct
mechanism of action allows MIs to retain full activity against viruses resistant to approved classes
of HIV drugs. Clinical proof-of-concept for MIs was established with the first-in-class MI, bevirimat
(BVM). In a series of trials, BVM was shown to be safe and effective in reducing HIV viral load in
infected individuals, however, a lack of uniform patient response was observed. Analysis of
patient virus revealed that a single amino acid polymorphism in the SP1 region of the viral Gag
protein was a primary determinant of patient response. This polymorphism involves a Val to Ala
change at SP1 amino acid 7: V7A. Approximately 50% of HIV-1 isolates contain V7 and are highly
sensitive to BVM while the remaining 50% contain A7 and lack sensitivity. DFH Pharma’s current
efforts focus on the development of next generation MIs with broad anti-HIV activity. Two of these
compounds, DFH-1220001 and DFH-1220002, exhibit the potency, ADMET properties and long-
acting formulation potential necessary to the successful development of modern HIV therapeutics.
The goals of the work outlined in this application will build on our successful phase II project efforts
(9R42AI155312-02). During the phase IIB period we will i) select a single 2nd gen MI development
candidate and advance that candidate into IND-enabling studies and ii) optimize the formulation
of the selected candidate for delivery as a long-acting agent (LAA). This 2nd goal recognizes that
the HIV treatment space is moving away from daily oral dosing towards formulations that support
weekly, monthly or even less frequent drug administration. We believe that our success in this
area as demonstrated in the phase II work will result in a novel MI drug development candidate
with LAA formulation potential advancing into IND-enabling studies.

Public health relevance
Project Narrative: Despite advances in the development of HIV drugs there remains a need for new therapies. Maturation inhibitors represent one class of new HIV therapies. DFH Pharma is focusing on the characterization and development of a new generation of maturation inhibitors for use as HIV therapeutics.